Acquisition of a Multimode Plate Reader

5602"21425414425443154544,&45118444161661482194946641296124442126192442412465461495444%566664241666919614224144422941421162616541%,4441'641,"6.6"42244(#581244$910121"194914!1966'"246514#6144$)6&46516249141645&52+46446192%412604-12%43845021465-56662,422164%156119149465442991464441*/212446!2629445&9941192414229&4655+6444945669965!294%2214226%16142414-422166661441!115241521494264916222664416
1'5%4.4529@22222591A1446@46124592655545454161245624515446116%24666619252629/1-19!4%>414-"144?4465&262%4141.164141-465641664544226121!262956&54229/41%1-41440611464647468+9'26496:%144492&161)9/-44449012647"9,4861694&499:4564961146424242256592414-11612442446119&2124549144949,9852!5266441946445454565429445245456444+169915251<6544446=1.41%51;;4!2=;1665644,226*64454-5&12644429411546649151946144419454516,244614&&254664
1162249&14-6%&44646216465&!464446626641966446&62,6&44221469465-149695469546922214665444552945114216414;6164521444&14&112 46,

Public health relevance
Project Narrative We request f1D1ds to purchase an Agilent BioTek Synergy Neo2 Hybrid Multi-Mode Microplate Reader as an equipment supplement for our Rl 5 grant entitled "Targeting Promoter G-quadruplexes with CRlSPRdCas9 forTranscription Regulation". This modem instrument is needed to replace a decade old plate reader which has limited capabilities and significantly lower sensitivity. Our research will establish the capabilities and limitations of CRlSPR technology in regulating gene expression of several prominent oncogenes.